Transcriptomics of Pain in Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
Patients with sickle cell disease (SCD) exhibit marked inter-individual heterogeneity in frequency
of acute pain events, or vaso-occlusive crises (VOC) and development of chronic pain. The nidus
of a VOC is typically the adhesion of a leukocyte to the endothelium, bringing with it a red cell
which deoxygenates and sickles, resulting in vaso-occlusion, ischemia, and pain. We therefore
collected SCD patient RNA from CD71+ cells (red cell precursors that still retain RNA) and
CD45+, leukocytes from individuals with and without chronic pain, and longitudinal collections
obtained at steady state, in VOC, and VOC resolution, and submitted these samples to TOPMed
for RNASeq analysis. We propose to leverage this transcriptome data from a well phenotyped
pediatric SCD cohort to address the unmet need of objective, quantifiable markers of acute and
chronic pain, and evaluate in the context of the germline and somatic mutations found in the same
subjects’ whole genome sequencing (WGS) data, also in TOPMed. Short term goals are to 1)
identify genes and pathways altered in the chronic pain state, 2) identify transcriptome changes
associated with pain events and their resolution, 3) generate a transcriptional risk score for the
development of chronic pain, and 4) determine which variants associated with chronic pain
development are likely to be causative through transcriptome wide association studies. Long
term goals are to use these findings to 1) develop targeted therapies to prevent and treat VOC,
2) therapies to treat chronic pain in SCD, and 3) biomarkers to distinguish acute pain events from
chronic pain. The ability to do so will allow providers to manage VOC appropriately and
aggressively, without inadvertently confusing chronic pain with an acute pain episode. Our
inability to distinguish between acute and chronic pain harms our patients, as the opioids that are
the mainstay for VOC treatment often worsen chronic pain through opioid induced hyperalgesia.
Our work will leverage TOPMed samples via our innovative transcriptomics analysis to identify
risk factors, therapeutic targets, and biomarkers of chronic pain, in order to improve the care and
quality of life of individuals living with SCD.

Public health relevance
PROJECT NARRATIVE Patients with sickle cell disease (SCD) experience acute pain events, or vaso-occlusive crises (VOC) which may progress to chronic pain. Our lack of understanding of the mechanisms and risk factors for progression to chronic pain, and lack of diagnostic biomarkers to identify VOC impairs our ability to appropriately treat VOC, and often results in potentiating and worsening chronic pain through excessive, inappropriate and ineffective exposure to opioids. Our innovative transcriptomics analysis of samples collected from relevant cell types from individuals with SCD with and without chronic pain, and paired genomics data, will address this unmet need.